Targeting MYB for Degradation using Microtubule-Destabilizing Agents

Project Summary
Microtubule-targeting agents, a class of drugs comprised of microtubule destabilizing agents (MDAs) and
microtubule stabilizing agents, have long been used to treat oncologic and inflammatory disease. While their
direct action on tubulin is well-established, the basis of their therapeutic activity in specific disease contexts and
tissue types is less understood. Intriguingly, microtubule stabilizing agents are almost exclusively used for the
treatment of solid tumors, while MDAs are predominantly used in the treatment of hematologic malignancies.
Both classes of tubulin targeting agents are antimitotic, yet the basis for their largely non-overlapping clinical use
is not formalized. We have determined that treatment with structurally diverse MDAs results in rapid, proteasome-
mediated degradation of MYB, a hematopoietic transcription factor that has been characterized as essential in
many hematologic malignancy models. Additionally, concurrent administration of microtubule stabilizing taxanes
counteracts MDA-induced MYB degradation, indicating that MYB degradation is an on-target effect of
microtubule destabilization. Importantly, overexpression of MYB in AML cells confers resistance to MDAs,
suggesting that MYB degradation may play a role in the antileukemic activity of MDAs. These observations
suggest that MDA-mediated degradation of MYB may account for the particular efficacy of MDAs in the treatment
of hematologic malignancies, which could inform future clinical use and development of microtubule targeting
agents.
The overarching objective of the proposed work is to unravel the molecular mechanisms of MYB
degradation in response microtubule disruption, thereby defining a strategy to target a central leukemic
dependency with clinically established microtubule targeting agents. This will be pursued from three angles:
defining the UPS machinery mediating MYB degradation in response to MDA treatment (Specific Aim 1),
characterizing the molecular, biochemical and structural features of MYB that facilitate its degradation by MDAs
(Specific Aim 2), and elucidating the mechanism by which microtubule destabilization engages the MYB
degradation pathway (Specific Aim 3). These aims seek to map the protein players, molecular features and
cellular events that associate microtubule dynamics with the stability of MYB. In particular, the role of MAP3K1,
a dual E3 ligase and kinase protein we found to mediate MDA-induced MYB degradation, will be investigated.
This study will leverage unbiased functional genomics and proteomics approaches to guide focused, molecular
studies. The mechanistic insights gleaned from this work will lay the foundation for future investigations into MYB
and its MDA-engaged regulators as potential biomarkers to guide the clinical application of microtubule-targeting
agents.

Public health relevance
Project Narrative MYB is a central dependency in blood cancers, yet there are no therapies directed against it. The proposed research will determine the mechanism by which MYB can be targeted for elimination using microtubule destabilizing agents, a therapeutic drug class already widely clinically employed.